GROWTH FACTORS AND HORMONES IN FETAL AND INFANT GROWTH

To measure levels of growth factors (epidermal growth factor (EGF0, insulin like growth factor (IGF) and transforming growth factor (TGF) in cord blood. To correlate the levels of growth factors with conditions affecting the growth and development of fetuses.